Studying axo-glial interface in aging

“Studyingaxo-glial interface in aging”
Peripheral neuropathies can result from inherited mutations, traumatic events, toxin exposures or be idiopathic,
and are commonly affecting more severely older people. While the peripheral nervous system has the intrinsic
capacity to regenerate, its regenerative properties decline severely during normal aging. Notably, age-
associated loss of Schwann cells plasticity, the glial cells of the peripheral nervous system that support axonal
regeneration and remyelination, was demonstrated in aging mouse models. However, once the aged Schwann
cells go pass this delay it is unclear if the impaired remyelination result from aged Schwann cells intrinsic
impairments in reengaging and remyelinating demyelinated axons. We hypothesized that aged Schwann cell
remyelination capacity is impaired due to intrinsic defects in recognizing remyelination axonal signals, limiting
nerve recovery, which constitute a new path of investigation in nerve repair during aging.
We have developed an in-vitro system, the pseudopod assay, designed to isolate Schwann cell pseudopod
formed in response to a suspension of neuronal cell membranes. This approach was proven to be effective at
identifying numerous molecules and signaling pathways essential for the initial interaction between Schwann cell
and axon during development. However, the molecules and potential remyelination signaling pathways present
at the axon-Schwann cell interface when Schwann re-engage and remyelinate demyelinated axons are unclear,
and how aging is altering those molecular events are unknown. Thus, we expand our pseudopod assay to identify
molecules and pathways altered during axon-Schwann cell interaction between aged and young Schwann cells.
To achieve this goal, we will (i) establish the proteomic profile of pseudopods generated by aged Schwann cells
when initiating contact with demyelinated axons, and (ii) compare the proteome generated by young Schwann
cells vs aged Schwann cells failing to reengage and remyelinate axons. We predict our results will create a
powerful new molecular dataset for the aging and neuroscience research community to use for future
investigation aiming at modulating juxtracrine axon-glia interaction in aged individuals.

Public health relevance
PROJECT NARRATIVE This proposal will define the molecules at the axon-Schwann cell interface in aged peripheral nervous system and will provide a core foundation for future in vivo investigations related to the failure of peripheral nerve regeneration and remyelination in the aging humans.